PHASE IV TRIAL OF SYNAGIS IN RSV INFECTION OF CF CHILD

This study is designed to determine whether monthly injections with Synagis reduce symptoms of RSV infection, hospitalization, use of pulmonary medications, and colonication with pseudomonas aeruginosa. A control group of children who get a sterile salt-water injection instead of study drug is necessary in order to detect favorable effects of Synagis. This is a randomized, double-blind, placebo-controlled trial. Children will get either Synagis or placebo-given by a shot in the thigh or arm muscle. Each child will have 1:1 (50%) chance of getting Synagis or placebo.